Durability of systemic and lung immune correlates of BCG-induced protection against M. tuberculosis infection

Project summary
Mycobacterium tuberculosis (M.tb) causes more deaths worldwide than any other infectious agent and is
increasingly characterized by antimicrobial resistance. An effective vaccination strategy to prevent establishment
of M.tb infection and progression to tuberculosis (TB) disease is a priority to achieve rapid control of the global
TB epidemic, but development and clinical testing of new vaccines is hampered by the lack of immune correlates
of protection. Revaccination of adolescents with the only licenced vaccine against TB, Bacille Calmette-Guerin
(BCG), partially protected against established M.tb infection, providing the first efficacy signal for a novel TB
vaccination strategy in a high-risk population. There is a one-time opportunity to leverage this existing cohort, as
well as newly enrolled participants in a larger confirmatory phase 2b clinical trial, to identify and test the durability
of immune correlates of protection against established M.tb infection in the lung, which could harbour critically
different immune responses compared to peripheral blood.
Blood and bronchoalveaolar lavage specimens will be collected to identify and determine longevity of vaccine-
induced systemic and pulmonary immune responses that correlate with protection against sustained M.tb
infection. The durability of vaccine-induced protection against infection ~6 years after vaccination will also be
explored.
Novel and robust technologies, such as polychromatic flow cytometry, mass cytometry and systems serology will
be applied to study adaptive and innate immune responses in participants enrolled in two BCG efficacy trials at
6 months and ~6 years after vaccination as well as 1 month and 4-5 years after primary M.tb infection. The
overarching hypothesis is that BCG vaccination induced multiple arms of the immune system and that a
combination of Th1/Th17 and IgA responses is associated with lower risk of established M.tb infection.
This approach will: 1) Identify and assess durability of BCG-mediated systemic and pulmonary immune
responses in M.tb-uninfected individuals; 2) Define systemic and pulmonary immune correlates of post-
M.tb exposure protection against established M.tb infection in participants experiencing transient (protected)
or sustained (unprotected) M.tb infection. Identification of vaccine-induced immune responses important for
protection against established M.tb infection would enhance our understanding of early containment of M.tb and
could inform immune correlates of protection against TB disease.
By extending the follow-up of the first BCG revaccination trial and comparing rates of M.tb infection in participants
from the BCG and placebo arms, we will also 3) Measure the durability of vaccine-mediated prevention of
sustained M.tb infection for at least 6 years post-vaccination, which, if significant, would provide impetus to
conduct larger trials testing for efficacy to prevent TB disease in endemic populations.

Public health relevance
Project narrative Outcomes of this study will provide data-driven evidence to improve novel vaccine candidates and vaccination strategies aimed at inducing protective immune responses against tuberculosis. The study focuses on a novel indication for a licensed product, the BCG vaccine, which is not currently administered to adolescents in countries with high tuberculosis burden. A realistic estimate of vaccine efficacy and duration of protection in susceptible populations are the main determinants to evaluate the public health impact and cost-effectiveness of such intervention.